Efficient estimation of auditory sensitivity and cognitive status using spoken-digit tests.

Project Summary/Abstract. Untreated age-related hearing loss (ARHL) is the most prevalent
cause of reduced quality of life for persons 55 and older in the US. There are 30+ million
hearing-impaired adults in this country, many of whom have never had a hearing test. One
reason is the lack of convenient, inexpensive and valid hearing tests that are available to both
individuals and hearing professionals. The goal of this project is to develop a family of tests of
auditory sensitivity and of related cognitive status that together measure functional hearing loss.
If such tests were widely available large numbers of those who suspect they may have hearing
loss would take them. This was demonstrated by over 3000 calls in a single day to the
telephone-administered National Hearing Test (NHT), without commercial promotion, only in
response to a few newspaper articles. The identification of spoken three-digit sequences in a
noise background, as used in the NHT, has been shown to correlate strongly with traditional
pure-tone measures of hearing loss. Digit-in-noise (DIN) tests have recently been shown to be
particularly efficient for screening, since they are reliable, convenient, and require neither sound
booths nor highly trained personnel for their administration. A family of DIN tests will be
designed to help distinguish poor speech recognition due to sensitivity loss from poor
recognition that reflects reduced cognitive processing. The tests will be implemented on
smartphones, tablets, desktop and laptop computers with Android or iOS operating systems.
The NHT developed earlier for landline phones (Watson et al., 2012; Williams et al., 2014), has
been taken by nearly 130,000 callers since 2014. Those data, plus audiograms from 700+
adults (veterans) who were given the DIN test together with other standard audiometry, will
guide test development. Optional spoken rather than keypad responses will make the test
accessible to children and to elderly adults with motor-control problems. Validation studies will
test 590 participants in three university hearing centers. DIN sensitivity tests will be validated in
relation to pure-tone audiograms, while cognitive-status tests will be compared to established
tests of working memory, executive function, and selective attention.
Audiogram slope
will be
estimated by comparing DIN-test performance using low-frequency masking noise, to that with
speech-spectrum noise. This new family of tests on a variety of platforms, will be designed for
use in the home, in schools, in primary-care physicians’ offices, in hearing clinics and in noisy
businesses. Widespread use of this family of screening tests can make personal knowledge of
hearing health as accessible as weighing oneself on the bathroom scale.

Public health relevance
Narrative. This project will develop a family of convenient, inexpensive, and reliable tests of functional hearing loss and associated cognitive decline, downloadable as applications for smartphones, tablets, laptop and desktop computers. These digit-in-noise tests are modeled after the National Hearing Test, which has been self-administered by landline telephone to nearly 130,000 callers, a small fraction of the 15-18 million US adults with treatable hearing loss who have never had a hearing test. Widespread use of these tests will encourage those who fail them to seek professional help for their hearing loss or, perhaps soon, to try the legally mandated FDA-approved web- or OTC-marketed hearing aids and other amplification devices.